UAB NORC Enrichment Program

PROJECT SUMMARY
The Enrichment Program, led by Dr. James O. Hill and Dr. Julie Locher, supports the overall mission of the
NORC to promote multidisciplinary basic, clinical, and translational research and research training on the
causal factors underlying nutrition- and obesity-related health problems and the generation and evaluation of
evidence on their consequences, prevention, and alleviation. The Enrichment Program comprises a broad-
based, comprehensive, and integrated set of activities that serves as a nidus for the formation of new ideas
and collaborations among nutrition and obesity researchers. The program includes: (1) a seminar series, (2)
national education and outreach (including short courses and national symposia), (3) special activities
(including workshops, roundtables, etc.), (4) training programs (including at the pre-doctoral and postdoctoral
levels), and (5) translational research and training. Our Enrichment Program aims to foster creative and
impactful research that benefits our investigators and the scientific community at large. In order to ensure that
our programs remain dynamic and responsive to our members’ needs, we continue to evolve with enhanced
activities.